Understanding Immunotype, a Novel Biomarker for Checkpoint Blockade Resistance

ABSTRACT
An estimated 44% of patients with cancer in the United States are eligible to receive immune checkpoint blockade
(ICB). FDA-approved ICB agents include α-PD-1 and α-CTLA-4 antibodies, but the majority of patients do not
benefit because their tumors are resistant to these agents. ICB treatment is expensive and may lead to serious
toxicity. Prospective identification of patients with ICB-resistant cancers would reduce unnecessary risk and cost
and give patients opportunities to seek more appropriate treatment options. To address the unmet need for a
peripheral blood biomarker for ICB effectiveness, we performed immune profiling of ICB-treated patients with
melanoma, using multiparametric flow cytometry to characterize immune cells in pretreatment peripheral blood.
Our analyses revealed a new peripheral blood immune profile—which we called Immunotype-1 (IT-1), defined
in part by the presence LAG-3+CD8+ T cells—as a promising biomarker of ICB resistance. This finding was
validated in an independent dataset of metastatic urothelial cancer. Patients with IT-1 have inferior overall
survival, progression-free survival, and response rates to α-PD-1 blockade. Leveraging our leadership in the
clinical development of ICBs, we have assembled one of the largest biobanks of peripheral blood samples from
>600 ICB-treated patients across cancer types. In this proposal, we aim to test the hypothesis that IT-1 is a pan-
cancer biomarker for ICB, reflecting an exhausted, tumor-specific LAG-3+CD8+ T cell population whose function
can be recovered for therapeutic benefit using α-LAG-3 blockade. The Specific Aims are to: 1) Phenotypically
and functionally characterize the peripheral blood LAG-3+CD8+ T cell population and determine if this population
is represented in the tumor microenvironment in patients with the IT-1 phenotype; 2) Determine the association
between IT-1 and clinical outcome in ICB-treated patients across cancer types; and 3) Assess whether IT-1
identifies patients who will respond to relatlimab (α-LAG-3) + nivolumab (α-PD-1). Our project is rooted in strong
clinical data and thus likely to identify a biomarker that is mechanism-based, clinically implementable, and most
importantly, therapeutically actionable.

Public health relevance
NARRATIVE Prospective identification of patients with cancers resistant to immune checkpoint blockade (ICB) would reduce unnecessary risk and cost and give patients opportunities to seek more appropriate treatment options. We have recently described an immune profile—which we called Immunotype-1 (IT-1)—as a promising biomarker of ICB resistance which can be detected in patients' peripheral blood prior to ICB treatment. In this proposal, we aim to test the hypothesis that IT-1 is a pan-cancer biomarker for ICB, reflecting an exhausted, tumor-specific LAG- 3+CD8+ T cell population whose function can be recovered for therapeutic benefit using α-LAG-3 blockade.